The role of attentional bias, counterfactual thinking, and protective behavioral strategies in ENDS users

PROJECT SUMMARY/ABSTRACT
The use of electronic nicotine delivery systems (ENDS) is on the rise and has been linked to nicotine
dependence. Abuse of ENDS is associated with a variety of adverse consequences, but as is frequently
observed with substance dependence, these adverse consequences are often insufficient to motivate and
sustain quitting attempts. Nicotine dependence remains a significant public health burden. New approaches to
facilitate quitting and sustain abstinence are needed, which will require novel insights into why a nicotine
addiction remains so difficult to overcome. Attention has long been understood to play an important role in the
addiction process, including nicotine addiction. Attention selects which aspects of sensory input receive
cognitive processing and thereby influence behavior. A substantial body of research has been devoted to
investigating the mechanisms by which smoking-related cues draw attention through reward-mediated
processes and the degree to which these biases predict quitting, along with developing attentional bias
modification techniques intended to facilitate quitting. These efforts have been largely unsuccessful and
therefore appear to fall short of accounting for the full range of information processing biases responsible for
the maintenance of a nicotine addiction. In the pursuit of a more comprehensive account of these biases, the
influence of aversive outcomes on attention offers promise. Interest in how aversive outcomes influence the
control of attention has grown in recent years, and robust biases towards aversively conditioned stimuli have
been identified in non-clinical samples. The role of aversive conditioning in attention could be especially
pertinent to understanding why individuals often maintain an addiction despite repeated exposure to its harmful
effects, which could reflect under-prioritization of threat cues that then fail to deter addictive behaviors.
Research suggests that cognitive avoidance strategies may improve attentional control when the individual is
given ample time to apply the strategy. Cognitive strategies, such as counterfactual thinking paired with
clinically backed strategies (i.e., protective behavioral strategies; PBS), may serve as the steppingstone
towards more adaptive attentional bias towards threat stimuli. However, how attention is influenced by
counterfactuals paired with PBS remains unexplored. To address this gap, the proposed research seeks to
identify how ENDS users and non-users differ with respect to attentional bias and CF processes. New Specific
Aim 1 focuses on the relationship between attentional bias and CF content, providing an initial glimpse into
how individuals with nicotine addiction engage in CF processes. New Specific Aims 2 extends this by focusing
on how CFs and attentional bias predict PBS engagement, intentions, and ENDS use measures. The findings
will provide necessary insights into the role of cognitive processes, such as CFs and attentional bias, in the
realm of nicotine addiction, the implications of which can help inform many of the cognitive-behavioral
techniques used in clinical assessments and intervention programs.

Public health relevance
PROJECT NARRATIVE The proposed project seeks to understand 1) how counterfactual (CF) processes, such as activation, generation, and content, are associated with attentional bias in nicotine- dependent and non-nicotine dependent individuals and 2) how CF and attentional processes predict engagement of protective behavioral strategies and electronic nicotine delivery system (ENDS) use. Attention to and consideration of aversive consequences are hypothesized to be blunted in ENDS users, thus underscoring the importance of developing effective interventions to facilitate successful quit attempts. Understanding patterns of CF processes in relation to attentional bias holds promise in providing insights that will lead to more effective approaches to facilitating cessation efforts.